How ubiquitin-carrying enzymes contribute to ubiquitin ligase specificity

In recent years novel drugs have been invented that induce proximity between a disease-causing protein and
an enzyme called a ubiquitin ligase that promotes the destruction of the problematic protein. This new drug
modality is feeding a billion dollar per year industry push to employ ubiquitin ligases to treat various human
diseases. Most of these efforts have been utilizing a family of enzymes called the Cullin-RING ligases (CRLs).
With some 200 members in humans, the CRLs collectively control approximately 20 % of ubiquitin-dependent
protein degradation in cells. As such, an appreciation for how these enzymes are regulated is of considerable
interest to a very wide audience. Human CRLs are known to partner with at least 7 additional enzymes, which
we refer to as ubiquitin-carrying enzymes (UCEs), that are required to promote CRL-dependent protein substrate
degradation. The control of CRLs is believed to be determined predominantly through their reversible
modification with a protein called NEDD8. Furthermore, it also was believed that UCEs act promiscuously
towards CRLs which would preclude CRL regulation at the level of CRL-UCE interaction. However, CRL-UCE
specificity is strongly implied by the recent structure of an active CRL. Preliminary results from our R01 grant
indicate that CRL-UCE specificity endows these pairs with exceptionally rapid rates of ubiquitin transfer,
potentially providing an additional layer of control of CRL function beyond neddylation. In consideration of these
observations, this administrative supplement seeks to obtain a stopped-flow instrument to develop biophysical
protein-protein interaction assays to measure the kinetics of formation of the protein complexes between UCEs
and CRLs. The results generated from these studies will help explain on a mechanistic level how CRL-UCE
specificity is achieved.

Public health relevance
The cullin-RING ligases (CRLs) are under intense investigation as targets for human therapeutics. CRLs are currently being employed by proximity-inducing drugs called proteolysis-targeting chimeras (PROTACs) to promote the degradation of disease-causing proteins, and the research proposed in this administrative supplement will provide mechanistic insight into how CRLs operate at the molecular level.